The Impact of Natural Disasters on Child Health

PROJECT SUMMARY/ABSTRACT
Climate change is increasing the frequency, intensity, and human toll of extreme weather events such as
floods and hurricanes. Children living in low and middle-income countries (LMICs) are particularly
vulnerable to the health impacts of these disasters because many live in areas that lack the resources to
mitigate, respond to, and recover from the devastation. Children might also be particularly sensitive to the
indirect health effects from disasters—morbidity and mortality due to compromised conditions such as
food security and clean water—as their health is more vulnerable to shocks. However, these indirect
effects are typically not included in the estimates of disaster deaths. Getting estimates of the indirect
burden of disasters on child health is therefore central for designing mitigation and adaptation strategies.
Recent evidence from Hurricane Maria in Puerto Rico suggests that indirect mortality impacts could far
outweigh the direct effects. In the proposed project we aim to improve measurement of the direct and
indirect child mortality burden of floods and storms (i.e., hurricanes, cyclones, and typhoons) in over 50
LMICs. These disaster types are particularly impacted by climate change and have a devastating human
toll. Specifically, we propose to (i) catalog the precise location and intensity of storms and floods in
Africa, Asia, and Latin America; (ii) link disaster events to child health records, (iii) estimate the impact
of these disasters on child mortality; and (iv) study the mechanisms and behaviors that contribute to
disaster related mortality, which will help inform mitigation strategies. This study will provide the first
wide-spanning empirical evidence of the indirect impacts of some of the most harmful disasters on child
health in LMICs. Our results will guide efforts to mitigate the consequences from these tragic events.

Public health relevance
PROJECT NARRATIVE The indirect impacts of disasters—morbidity and mortality due to compromised conditions such as food security and clean water—are typically not included in estimates of disaster deaths. Child health is particularly sensitive to such compromised conditions and understanding the indirect burden of disasters on child health is central for designing mitigation and adaptation strategies. This project aims to estimate the indirect child mortality burden from floods and severe storms around the world.